Training Program in Vision Science

Project Summary
Thirty-two Vision Science preceptors, members of the Group in Vision Science from 9 major
departments on the U.C. Berkeley campus (optometry, psychology, public health, molecular and
cell biology, neuroscience, public health, computer science, electrical engineering, chemical
engineering and physics), seek support for 12 pre- and 4 post-doctoral trainees. Support is
sought for 2 years of graduate training toward the PhD, for the pre-doctoral trainees and the 3
health-profession degree seeking trainees (OD, MD etc.), and one year for the post-PhD trainee.
The interdisciplinary program in Vision Science has been in existence for over 70 years. There
are currently 38 pre-doctoral students engaged in studies leading to the PhD in Vision Science.
Among these students there are 5 students who hold an OD degree and one who holds a DVM
degree.
There are additional 69 postdoctoral fellows currently training in the laboratories of the faculty
of the Group in Vision Science. Of the more than 241 trainees who have completed research
degree training in Vision Science (almost all PhD) to 2017, the majority are now active vision
researchers. Many have successfully competed for independent research funding. Our purpose is
to attract outstanding trainees who will develop independent and productive vision research
careers.
Pre-doctoral and health profession degree trainees, most with additional formal basic science
training (e.g., cell biology, immunology, neurobiology, or epidemiology, biostatistics), will earn
Ph.D. (Vision Science) degrees. Each pre-doctoral trainee will receive stipend support during the
first two years from the NIH Training Grant supplemented by Departmental and University
fellowships. After the initial first two years, the support will be provided entirely from resources
of the University of California (primarily through individual faculty research grants). Health
professional trainees will receive 3 years of support on the Training Grant. Trainees will meet
formal course and teaching requirements and will be trained in laboratory research techniques in
both basic sciences and vision science. The training is augmented by the extensive resources of
the Berkeley campus and the technical support provided to the Group in Vision Science by the
NEI Core Grant.

Public health relevance
Project Narrative The Group in Vision Science on the UC Berkeley campus is engaged in training pre-doctoral and post-doctoral trainees from a broad range of backgrounds to generate new knowledge about the eye and visual system in health and disease - from the basic mechanisms of vision through translation and application of new therapies to people with vision disorders.